Multidisciplinary Research Training in Palliative Care

Project Summary / Abstract
The goal of this competitive T32 renewal application is to continue a research training program that is
preparing postdoctoral physician and PhD fellows for careers as investigators addressing priority research
topics at the interface of geriatrics and palliative care. Funding is requested for 4 post-doctoral trainees per
year, the same number of trainees as in year 5 of the current T32 award. This T32 research training program
supports postdoctoral training for both physician-scientists and Ph.D.-scientists.
The primary impetus for the current T32 training program, and this requested competitive renewal, is the
urgent need for a pipeline of well-trained investigators positioned to advance the field of palliative care,
ultimately improving care for older adults with serious advanced illness. This T32-supported research training
program addresses a scientific knowledge and research workforce gap in aging and palliative care, namely, the
paucity of robust research evidence and a pipeline of investigators.
The initial funding period for this T32 focused on: 1) recruiting and retaining outstanding post-doctoral trainees;
2) supporting their research training through experiential and didactic instruction; 3) ensuring the highest level
of academic success through conscientious monitoring of thoughtfully constructed individual research career
development plans; and 4) enhancing the mentoring skills of junior mentors through co-mentoring with more
experienced senior mentors, expanding the cohort of senior mentors in palliative care research. These goals
remain at the heart of this program and are reflected in the organization and focus of this training grant.
The proposed competitive renewal builds on the demonstrated successes over the first funding period,
enhancing the existing approach through a refined curriculum that meets the identified and evolving needs of
the field and expanding the Program and Affiliated Faculty. Success in the initial 4 years of this T32 is
demonstrated by ability to: 1) fill positions with 7 outstanding trainees and foster an ongoing pipeline of trainee
candidates; 2) produce academically successful and productive trainees who are publishing peer-reviewed
manuscripts, presenting in national venues, obtaining intra- and extra-mural grant funding and attaining
research-focused faculty positions; 3) expand the cohort of research mentors by engaging more junior faculty
as co-mentors; and 4) enhance geriatric palliative care research capacity through deliberate and strategic
interactions amongst programs and faculty, bringing new skills and expertise to and engaging new senior
mentors in palliative care research. This T32 has, and with ongoing funding will continue to have, immediate
local, regional, and national influence by developing a cadre of skilled, productive researchers.

Public health relevance
Project Narrative Despite advances in clinical care and education, gaps remain in the evidence base to inform clinical palliative care, especially for older adults. One of the most important ways to advance care for older adults with advanced illness is through the development of junior investigators who will contribute to generation of evidence and build the academic critical mass necessary for the future of the field. Although clinical fellowship programs in palliative care have been growing in number and quality, there remains a paucity of research training opportunities in palliative care. The goal of this T32 is to prepare postdoctoral physician and PhD scientists for careers as aging-related palliative care researchers.